PHYSIOLOGICAL BASIS FOR WEED COMPETITION IN N2 FIXING LEGUMINOUS CROP SYSTEMS

Mouse embryos between 8.5 and 19.5 days of gestation will be investigated on the 9.4 Tesla system. We will be testing pre-processing techniques of the embryos to determine what fixation techniques and what reaction mixes provide the most useful information for each embryo stage. Specifically, we will determine whether permeabalization and reaction with ferric and ferrous salts contribute to enhanced contrast of neural crest structures in 11.5 to 14.5 day mouse embryos. We will also search for the source of enhanced signal in developing bone as demonstrated in embryos between 14.5 days and birth. We will also scan embryos which have been perfused with Gd-BSA-DTPA to complete our time-series study of cardiovascular development in the normal embryo.